Making DeepEdge, a tool for ultrasound analysis, cloud-accessible.

Project Summary This project is a supplement to the parent NIH award (DC-002717) “Links Between Production and Perception in Speech”, intended to enhance software tools for open science. The parent project investigates the variability and flexibility of speech production through the human vocal tract and how listeners perceive the phonologically meaningful primitives within the speech signal, through a series of speech production and perception experiments. In the speech production experiments, ultrasound imaging provides a non-intrusive and cost- effective technique to measure tongue movements. To facilitate the analysis of tongue measurements in ultrasound images, we developed a software program to track midsagittal tongue contours automatically on a proprietary platform. The aim of this supplement project is to migrate our software program to a cloud platform with other improvements, in order to increase robustness, interoperability, sustainability, portability and performance.

Public health relevance
Project Narrative This supplement project aims to enhance an AI-powered software tool for automatic tongue contour tracking in ultrasound video, by releasing it to a publicly accessible cloud platform. This project will benefit researchers and clinicians in speech-related studies when using ultrasound imaging to measure tongue positions and movements.